Regulation of Aberrant Protein Production

ABSTRACT
Defective proteins result from mutations, mistakes of transcription, stress, and other factors. These aberrant
proteins are often toxic and cause a number of human diseases. There are several quality control (QC)
pathways in the cells: nonsense-mediated, no-stop, and no-go decays for defective mRNAs, and the
ubiquitin/proteasome system for already synthesized misfolded proteins. Recently, we discovered a new QC
pathway called Regulation of Aberrant Protein Production (RAPP). RAPP is a preemptive QC, it monitors
proteins during their synthesis at the ribosome, senses defective proteins and degrades their mRNA templates.
It is the first example of transferring information about aberrant proteins to mRNA degradation machinery.
Normally, nascent polypeptides emerged from the ribosome exit tunnel interact with targeting or folding factors.
When a mutation prevents these interactions, the Ago2 protein, a sensor in the RAPP response, detects the
loss of these important interactions and triggers mRNA degradation. Surprisingly, Ago2 endonuclease activity
is not required in the process. Thus, the molecular mechanism of RAPP is not well understood, very little is
known about its mRNA degradation machinery and its substrates. The proposed project will fill these gaps in
knowledge. Our hypothesis is that RAPP is a general protein quality control pathway that consists of three
major steps: detection of an aberrant nascent chain complex, translational repression, and formation of
specialized cytoplasmic foci for degradation of the aberrant mRNA. Our specific aims are designed to test this
hypothesis and directed to (1) elucidate the mechanism by which protein expression is down-regulated in
RAPP, and (2) determine whether RAPP is a general mechanism of protein quality control for secretory and
membrane proteins in mammalian cells. The proposal involves application of comprehensive in vivo and in
vitro approaches, including our unique technology, iPINCH, for identification of Proteins Interacting with
Nascent Chains. Determining the scope and mechanism of RAPP will impact the field of protein quality control
research by providing a better understanding of cellular defense against erroneous and potentially toxic
proteins.

Public health relevance
PROJECT NARRATIVE Living cells often produce defective proteins that may lead to diseases. Regulation of Aberrant Protein Production (RAPP) is a novel protein quality control that senses defective proteins during synthesis and degrades their mRNA templates, however, little is known about its mechanism. The proposed project will elucidate the RAPP mechanism and establish its generality. ! !